Computational systems immunology core

Abstract
The three research projects of this program project grant utilize single cell genomic strategies and
complementary imaging strategies to define cell-cell interactions in target tissues in systemic lupus
erythematosus (SLE) and rheumatoid arthritis (RA). These projects will be used to develop insight into the
development, function, localization, and interactions of B and T lymphocytes (Project 1), monocytes (Project 2),
and fibroblasts (Project 3). Key to understanding these cell-types is the effective interpretation of complex high-
dimensional data sets. The Computational Systems Immunology (CSI) core will support the analytical and
computational needs for the three projects. This core will build from our experience with the Accelerating
Medical Partnerships (AMP) RA/SLE program where analysis of high dimensional single cell data sets has now
given us the first look at the constituent immune and stromal cellular populations. CSI will 1) employ
computational strategies to analyze and integrate multiple single cell RNA-seq datasets to define key cellular
populations 2) use trajectory analysis to define transitional states between cells. 3) Define clonal populations
with repertoire sequencing and 4) Define the relationship between cell-cell interactions and transcriptional
states. The CSI is uniquely positioned to analyze and integrate RA and SLE data with its long-standing
expertise in rheumatic diseases, systems biology, and imaging analysis.